Tumor-Targeted STING Agonism in Head and Neck Squamous Cell Carcinoma

Head and neck squamous cell carcinoma (HNSCC) is a lethal disease that kills ~200,000 people annually
worldwide. Resistance to DNA-damaging agents (i.e. radiation therapy [RT] and chemotherapy) is a significant
problem in both the locally advanced and recurrent/metastatic settings, ultimately leading to patient death.
Attempts to improve responses to DNA damaging agents with programmed death-1 (PD-1) axis agents have
been limited, indicating the crucial need to identify novel determinants of the DNA damage response (DDR).
Towards this end, through use of a whole-genome CRISPR screen, we have uncovered a novel role for tumor
STING (stimulator of interferon genes) as a critical determinant of the tumor cell intrinsic response to DNA
damage. We show that loss of STING expression enhances tumor cell intrinsic resistance to DNA-damaging
therapies through alterations in reactive oxygen species (ROS) homeostasis and DNA damage, and conversely
that activation of STING enhances ROS generation. To overcome poor pharmacokinetics (PK) and lack of tumor-
targeting that have led to the failed clinical use of current STING agonists (STINGa) we have developed a novel
tumor-targeted STINGa using pHLIP (pH low insertion peptide). pHLIP is a clinically utilized technology that
takes advantage of the acidic tumor microenvironment (TME) and delivers its cargo specifically to the tumor and
TME. In our preliminary data we show that STING activation with pHLIP-STINGa enhances the effects of DNA-
damage in a biomarker (tumor STING)-dependent manner, resulting in tumor cure.
Based upon these preliminary data we will test the hypothesis that STING serves as an actionable target
to enhance the effects of DNA-damaging therapy through modulation of tumor intrinsic (ROS and DNA damage)
and immune-mediated responses in a tumor STING dependent manner. In Aim 1 we will develop an optimized
tumor-targeted, dimeric pHLIP-STINGa to overcome the major shortcomings of existing failed STINGa, thus
allowing for clinical translation of these findings. In Aim 2 we will test the hypothesis that pHLIP-STINGa will
synergize with ROS-dependent DNA damaging therapies in a tumor STING-dependent manner and dissect the
mechanism of STING in regulating ROS and DNA damage levels. These studies will further our biologic
understanding of the interaction of the innate immune machinery and cell intrinsic DDR with the potential to guide
therapy selection. Lastly, in Aim 3 we will use pHLIP-STINGa to identify the immunologic mechanisms of the
tumor STING-dependent control of DNA-damaging therapy and PD-1 combinations in HNSCC. We will test the
hypothesis that the increased tumor killing seen with pHLIP-STINGa + DNA-damage combinations will enhance
responses to PD-1 axis agents in otherwise resistant, immunologically cold HSCC . We will also define forced
STING re-expression by DNA methyltransferase inhibition as a strategy to restore sensitivity to pHLIP-STINGa
combinations in STING-deficient HNSCC. The long-term goal of this study is to translate our findings into a
clinical trial that tests pHLIP STINGa + DNA damaging therapy treatment combinations in HNSCC.

Public health relevance
PROJECT NARRATIVE Resistance to combinations of DNA damaging agents and immunotherapies, ultimately leading to patient death, remains a substantial problem in head and neck squamous cell carcinoma (HNSCC), thus indicating the need to define new, actionable determinants of the DNA damage response. We have recently uncovered a novel role for tumor STING (stimulator of interferon genes) as a critical determinant of the tumor cell intrinsic response to DNA damage through regulation of reactive oxygen species homeostasis. In this proposal we will define the STING pathway as a biomarker-driven (tumor STING), actionable target to improve responses to standard therapies in head and neck cancer through 1) development of a novel tumor-targeted pHLIP (pH-low insertion peptide) STING agonist to overcome major shortcomings of prior failed STING agonists, 2) dissection of the tumor intrinsic and immune mediated mechanisms of pHLIP-STING agonist treatment combinations and 3) definition of DNA methyltransferase inhibition as a strategy to restore HNSCC STING expression and sensitivity to pHLIP-STING agonist treatment combinations with the ultimate goal of clinical translation to improve outcomes in patients with HNSCC.